Using machine learning to understand cardiopulmonary and renal end organ complications for individuals with SCD

PROJECT SUMMARY/ABSTRACT
Individuals with sickle cell disease (SCD) are at risk of developing numerous chronic complications including
cardiopulmonary and renal (CPR) end organ complications, which are associated with early mortality. To better
understand the risks of CPR end organ complications and outcomes of individuals with SCD and CPR end
organ complications, large epidemiological studies are needed. However, given that SCD is a rare condition,
there remains a lack of large epidemiological studies focused on CPR end organ damage among individuals
with SCD. In this project, we propose to establish a large patient cohort leveraging existing big data sources of
the electronic health record (EHR) and administrative claims to determine the risks of CPR end organ
complications and factors associated with frequent acute care use among those with CPR end organ
complications and SCD. In this project, the candidate will obtain training in machine learning models used for
risk prediction along with training for the causal inference framework and recently developed counterfactual
based machine learning ensembles. The candidate has established a mentoring team with content expertise in
SCD, health care services research, and machine learning mentor. In addition, the scientific advisory
committee includes members that cross discipline and complement the mentoring team. The skill sets acquired
during the award period will be directly applied to the proposed project and help address many of the
unanswered questions in the field of SCD.

Public health relevance
PROJECT NARRATIVE Individuals with sickle cell disease (SCD) and cardiopulmonary and renal (CPR) end organ complications have high acute care utilization and mortality rates. The risk factors for SCD-related CPR end organ complications are unknown and also it is unclear if conventional SCD management strategies can prevent the hospitalizations and/or emergency department visits for those with CPR end organ complications. In this proposal, the investigator proposes to use machine learning approaches to identify risk factors for CPR end organ complications and protective factors associated with less frequent acute care utilization among individuals with SCD and CPR end organ complications.